Safety Training and Injury Prevention for the Next Generation of New England Fishermen

Safety Training and Injury Prevention for the Next Generation of New England Fishermen
Project Summary
The State of Maine’s economy depends on fisheries and maritime industries and the lobster
industry is arguably the most valuable east coast fishery, and the second most valuable fishery in
the nation in 2019 at 132 million pounds in landings with an ex-vessel value of $540 million[1].
The fishery is a remarkable example of co-management but yet over the past three decades the
fleet has observed a notable graying of the fleet. In response to this, MCCF invested in the next
generation of fisheries stewards through the Eastern Maine Skippers Program (EMSP), which
continues to evolve in response to new demands. EMSP is delivered through an educational
collaborative with local schools and teachers, which enables us to reach as many as 80 and 110
students per year, and in the most needing and impoverished counties in Maine with 18%
poverty rates, and 12% unemployment rates (Hancock, Washington, Knox counties). This area
encompasses commercial lobster fishing zones A, B & C, which together represent 72% of the
6,500 active lobster licenses held in Maine and generate upwards of 80% of household income in
these rural underserved communities[1]. Educating these students about sustainable fishing
industries is not only beneficial for Maine’s economy, but vital to New England. The need for
innovative and frequent safety training and occupational wellness education is also evident
considering two recent entanglement fatalities (Stonington, ME and Jonesport, ME) and 18
emergency responses from Search and Rescue by U.S. Coast Guard east of Rockland in Maine
over the past two years. The state of Maine has also been proactive in addressing maritime safety
legislation, including being the first state to require new boater certification. In response, MCCF
proposes to deliver effective safety training, addressing the immediate needs of Maine’s primary
fisheries over a three-year period, promoting maritime safety relevant behavior in coastal
community fisheries in Maine through the following core activities: 1.) Deliver safety and
survival training for annual cohorts of students from eight high schools, including recent
post-graduates for a total of 250 students over 3-years; 2.) Build capacity in the project area by
training 2 additional qualified drill conductor instructors in eastern Maine; and 3.) Deploy
training materials created in previous grant period pertaining to repetitive biomechanical
overload and occupational hazards including deck safety, vibration, noise, and UV radiation. We
anticipate that the outcomes of our proposed training projects will show changes in the
safety-relevant behavior through a cultural shift in safety minds behavior in Maine’s commercial
fisheries, and reduce risk of injury through cultural shift in attitude and awareness of safety.

Public health relevance
MCCF submits this proposal to deliver effective safety training, addressing the immediate needs of new entrants into Maine’s commercial fisheries over a three-year period, and thereby promote maritime safety relevant behavior in coastal commercial fisheries in Maine. The need for innovative and frequent safety training and occupational wellness education is evident considering two recent entanglement fatalities (Stonington, ME and Jonesport, ME) and 18 emergency responses from Search and Rescue by U.S. Coast Guard east of Rockland in Maine from within the commercial fishing industry. We anticipate that the outcomes of our proposed training projects will show changes in the safety-relevant behavior through a cultural shift in safety minds behavior in Maine’s commercial fisheries stemming from the involvement of the next generation of fishermen, build additional training capacity, and reduce risk of injury through cultural shift in attitude and awareness of safety systems.